Development and testing of the Novocuff device to prevent infant morbidities and mortalities caused by preterm birth.

PROJECT SUMMARY/ABSTRACT
Preterm birth (PTB), delivery < 37 weeks gestational age (GA), is the leading cause of death for infants under the
age of one. In addition, PTB is associated with costs of $26 billion dollars per year in the United States (US) - accounting
for half of all infant-related hospitalization costs. One of the greatest risk factors for spontaneous PTB, which comprises
70% of all PTBs, is a short cervix (i.e. shortened cervical length on transvaginal ultrasound).
There is currently no FDA approved device that addresses the 360,000 annual spontaneous PTBs in the US; there
are also no consistently proven pharmacologic therapies. The only effective mechanical treatment option available is a
cerclage, a surgical procedure involving suturing the cervix closed. There are however, numerous limitations to
cerclages: 1) as a surgical procedure it requires access to an operative room, personnel, and its associated costs, 2) it is
only be performed up to fetal viability (22-24 weeks GA), 3) it requires a highly skilled trained provider, usually a
specialist 4) it is not recommended for patients with multiple gestations 5) it is indicated (and proven beneficial) only in
patients with a shortened cervical length and prior PTB/2nd trimester pregnancy loss and 6) while it may be performed in
other populations emergently for cervical dilation as a rescue cerclage, has shown no consistent benefit.
Novocuff Inc., a California-based small business, is developing an easy to use, minimally invasive, non-surgical
device intended to reduce the risk of spontaneous PTB. The Novocuff device is designed to support the cervix, assist in
maintaining cervical length, and adjust the angle of the cervix to decrease the forces that lead to cervical shortening.
Preliminary benchtop studies have demonstrated Novocuff’s ability to apply circumferential compression around a
cervix model without causing trauma to the cervical tissue. The risk profile of the Novocuff device is considerably lower
than the cerclage since it is non-surgical, not embedded in the cervix, and can be placed/adjusted in an office setting.
The decreased risk profile would not only allow it to be used in lieu of a cerclage, but also for those in whom a cerclage is
not indicated (i.e. twins, nulliparas), and >24 weeks GA, increasing treatment options for physicians and patients.
Novocuff has the support of key opinion leaders at respected educational research institutions. These physicians
have provided valuable clinical input regarding the design and application of the Novocuff device and will assist in
verifying the design during any future benchtop studies. The next step in design verification and the key focus of the
proposed Phase I project, is to determine the feasibility and clinical readiness of the Novocuff device. Our specific aims
are to 1) test that the Novocuff device can apply comparable forces to the cervix as a surgical cerclage, 2) test Novocuff
biocompatibility and bioburden and 3) test that the Novocuff device passes all functional requirements. At the end of
Phase I, Novocuff will have completed all the necessary preclinical testing to demonstrate mechanical readiness for a
clinical trial. Phase II efforts will focus on supporting an FDA submission. The broad, long-term objective of this Phase I
grant application is to improve clinical treatment options that bridge the gap between potentially viable and healthy
newborns, decrease the risk of PTB, and to reduce infant mortality, with its associated effects on maternal health.

Public health relevance
PROJECT NARRATIVE Preterm birth (PTB) is the leading cause of death for infants under the age of one, costing the United States $26 billion dollars per year, and accounting for half of all infant-related hospitalization costs. One of the primary causes of spontaneous PTB is a short or weak cervix that cannot support the pregnancy. There are limited treatment options, with limited benefit, for cervical shortening. Novocuff Inc. is developing an easy to use, minimally invasive, non-surgical device intended to prevent PTB by maintaining the cervical strength and integrity across a diverse group of populations.